Cancer Immunoprevention Network (CIP-Net) Resource Coordinating Center

Project Summary/Abstract
The goal of our proposed Data and Resource Coordinating Center (DRCC) application is to catalyze
collaboration across the Cancer Immunoprevention Network (CIP-Net) and to manage, integrate and
disseminate the data and resources generated through the network. By leveraging cutting-edge, multidisciplinary
team approaches, we will support CIP-Net in fostering a collaborative community of cancer immunoprevention
researchers, collectively working to understand the basic mechanisms of immunoprevention, discover novel
immunoprevention strategies, and develop and test preclinical interventions. Our strategy is to boost the
productivity of CIP-Net investigators by fostering a collaborative research community, accelerate CIP-Net
research by removing barriers to accessing analytics expertise, improve the interoperability and usability of CIP-
Net data by deploying best practices for data standards and harmonization, and unlock the full potential of CIP-
Net activities by sharing data and resources with the broader scientific community.
First, we will establish an effective administrative infrastructure and organizational process to coordinate
CIP-Net activities, building on our proven and continuously improving systems that currently support the
coordination of NCI programs. Second, we will ensure that CIP-Net data are harmonized using standards
interoperable with the broader cancer data ecosystem and findable through a centralized virtual repository,
leveraging our extensive track record and robust systems for collaborative data sharing and dissemination in
consortium studies. Third, we will provide multidisciplinary analytics expertise to support CIP-Net’s collaborative
research, drawing on our collective strengths in biostatistics, bioinformatics, and biomedical informatics from
Roswell Park’s Department of Biostatistics & Bioinformatics. Fourth, we will actively promote CIP-Net and
engage diverse stakeholders to build an inclusive community that leverages a range of perspectives and
approaches to address key scientific questions in immunoprevention. Taken together, we envision that our
DRCC, in close collaboration with the CIP-Net stakeholders, will enable us to support highly effective and
innovative translational studies that address the critical unmet needs in cancer immunoprevention.
The main deliverables include: administrative and organizational support to coordinate network activities
and facilitate communication and collaboration (Aim 1); policies, workflows, and infrastructure to ensure that all
resources generated by CIP-Net are harmonized using standards interoperable with the broader cancer data
ecosystem and findable through a centralized virtual repository; multidisciplinary analytics support to accelerate
CIP-Net research progress, along with innovative solutions to address CIP-Net’s evolving needs (Aim 2); and
community-building and outreach efforts to support immunoprevention research, integrate patient advocates into
CIP-Net, and coordinate career development opportunities for early-career scientists (Aim 3).

Public health relevance
Project Narrative Despite advances in immunoprevention for virus-associated cancers, preventing cancers not caused by infectious agents remains a significant challenge. The goal of our proposed Data and Resource Coordinating Center (DRCC) application is to catalyze collaboration across the Cancer Immunoprevention Network (CIP-Net) and to manage, integrate and disseminate the data and resources generated through the network. By leveraging cutting-edge, multidisciplinary team approaches, we will support CIP-Net in fostering a collaborative community of cancer immunoprevention researchers, collectively working to understand the basic mechanisms of immunoprevention, discover novel immunoprevention strategies, and develop and test preclinical interventions.